Administrative Core

PROJECT SUMMARY/ABSTRACT – Administrative Core
The Administrative Core advances the scientific mission of CAPS by: providing scientific
direction, administrative leadership, and a structure for key decision-making functions;
developing and implementing strategic plans; monitoring and evaluating progress; and
ensuring efficient administrative operation. In this continuing renewal application, we take a
Systems Theory approach, recognizing that CAPS is both a highly integrated collection of
cores unified to accomplish its mission and a system of processes interacting to maximize
productivity. Thus, CAPS's management strategies focus on its capacity to analyze strategic
environments, develop and enact tactics in response to environmental demands, and sustain
an adaptive and productive organizational culture. By synergizing across cores, CAPS
ensures that the “whole is greater than the sum of its parts.” CAPS learns from its
experiences and evolves nimbly and dynamically, continually enhancing its capacity to create
and respond to scientific, institutional, and funding needs to scale-up HIV science and attend
to the critical needs of highly impacted populations. This infrastructure allows CAPS to
remain a global resource for the wider HIV community, including scientists and public health
and community partners. In this renewal, the Core will leverage its capacities to support
research on two themes: (1) co-occurring and multiplicative factors that fuel HIV transmission
and poor health outcomes and (2) HIV-related health systems.